Administrative Core

ABSTRACT:
The Core A (Administrative Core) is led by the Program's PD/PI, Joe “Skip” G.N. Garcia MD, who will provide
essential oversight of program and administrative operations to ensure overall direction and organization of the
entire Program. Dr. Garcia and Core A members will be responsible for program direction and evaluation,
program operations, and fiscal and scientific oversight. They will organize monthly PPG meetings, work with the
PPG's Internal and External Scientific Review Panels and PPG Leaders, and coordinate PPG activities. The
PPG Core A Program and Grant Administrator/Research Coordinator, reporting directly to Dr. Garcia, will handle
day-to-day research details (research project coordination/oversight in addition to intra- and inter-institutional
project utilization of the Cores and reagents exchange) and day-to-day administrative details (financial and
administrative operations). In addition, this Core will provide accounting support that will ensure appropriate
fiscal and scientific oversight, monitoring and compliance with federal and institutional grant management
regulations, the latter through several formal mechanisms. The objectives of the Administrative core are: (i) to
centralize all administrative actions and financial recording keeping; (ii) to prepare scientific and financial reports
as required by the university and the NHLBI; (iii) to ensure that the PPG research meets the highest standards
through periodic review by the internal and external review panels; (iv) to facilitate the use of common resources;
(v) to provide the projects and cores with a review of all expenditures on a monthly basis as well as dealing with
University Accounting and Grants offices concerning grant budgets; (vi) to provide the communication venues
that foster exchange of scientific information and ideas and allow highly seamless communication between PPG
scientists in Chicago and Tucson; (vii) to coordinate the regular virtual or in-person retreats between UA and
UIC investigators for quarterly meetings, in Tucson and/or Chicago, in addition to the annual ATS conference.
As this communication is vital to the success of the program, Core A personnel, will orchestrate the video
conferencing of the: i) weekly meetings of individual Project and Core teams, ii) biweekly meetings of the
Program Committee (led by Core A Leader and PPG PD/PI) where Project and Core leaders discuss scientific
and administrative matters, and iii) regular monthly research seminars that will allow PPG investigators to present
their work in progress to other researchers. In this A1 PPG renewal application, Core A will facilitate workflow
between Chicago and Tucson, especially with regard to Core B, C, and D experiments and the critical exchange
of reagents between Projects. Finally, Core A will coordinate the inter-project, inter-departmental, and inter-
institutional collaborative arrangements and evolve new arrangements as deemed necessary for the scientific
progress of the Program Project as a whole. Together, these coordinated administrative services will ensure
optimal financial practices, facilitate frequent and productive communications between PPG scientists, and
promote the high quality scientific interactions necessary to meet the goals of this translational PPG.